Ribosome Heterogeneity as a Mechanism for Metabolic Regulation - Research Supplement to Promote Diversity in Health-Related Research

PROJECT SUMMARY/ABSTRACT
The current epidemic of obesity and metabolic syndrome has been linked to alterations in diet and lifestyle.
Although human tissues demonstrate remarkable metabolic plasticity in response to physical activity and
dietary exposures, our understanding of the mechanisms that underlie the beneficial or deleterious effects of
exercise or nutrient exposures on skeletal muscle and hepatic metabolism are incomplete. The goal of this
study is to uncover new mechanisms that underlie enhanced skeletal muscle insulin sensitivity following an
acute bout of exercise and changes in hepatic glucose homeostasis and insulin sensitivity in high fat diet and
time-restricted feeding paradigms. I will test the radically novel hypothesis that remodeling of ribosomes in
these tissues rapidly generates changes in the proteome and serves as a mechanism for metabolic plasticity.
This work will advance our understanding of how environmental cues shape metabolic physiology and has the
potential to identify new targets for preventive therapies aimed at improving human metabolic fitness.

Public health relevance
PROJECT NARRATIVE This study will evaluate novel ways in which acute exercise and changes in nutrient exposures induce rapid alterations in skeletal muscle and liver metabolism that impact insulin sensitivity. The findings will provide a new understanding of how the body achieves metabolic fitness and how metabolism is perturbed in diabetes and metabolic syndrome.